Short-term Research Training for Veterinary Students in Wisconsin

Project Summary
The purpose of this program is to provide a 12-week mentored research experience for veterinary students at
the University of Wisconsin-Madison. The traditional veterinary curriculum lacks formal training in performance
of research: therefore, this summer research exposure experience is an essential way to expose DVM
students to the research process within a tier-one research institution and encourage them to consider
research-oriented careers. This program has been integral to our ability to recruit prospective veterinary
medical students with research interests to our DVM professional program at the University of Wisconsin-
Madison. It has also been fundamental to our success in increasing the number of minority veterinary students
pursuing research training, informing veterinary medical students of careers in research, and exposing
veterinary students to important discussions related to research ethics, responsible conduct of research, and
the skills and tools required for successful careers in research. The over-arching objective of this program is to
introduce veterinary medical students to research. They gain a working knowledge of how to identify a
problem of significance to the health and welfare of animals and/or humans, learn how to develop a hypothesis
to test focused questions, build a plan to identify and validate appropriate techniques to pursue, analyze and
report data. The students undergo workshops to promote excellent science communication in both oral and
written formats. Trainees participate in regularly scheduled laboratory meetings and weekly seminars designed
specifically for these goals within the 12-week summer timeline. Trainees are expected to present the results of
their research at the summer veterinary research scholars symposium (typically the NIH-Boehringer Ingelheim
Veterinary Scholars Program Symposium held annually in August) or at seminars or symposiums held at the
University of Wisconsin School of Veterinary Medicine. The University of Wisconsin in general, and the School
of Veterinary Medicine in particular, provides an ideal environment to support short-term research training for
veterinary students. The proposed program is designed to integrate with additional graduate research training
programs within the School of Veterinary Medicine to provide a continuum of support for veterinary students
that are inspired to pursue advanced research training.

Public health relevance
Project Narrative The National Academies of Science (NAS) and several other entities have identified a critical shortage of veterinarians in research, and the NIH has identified a need for increased emphasis in clinical and translational research. These issues have a direct bearing on the health and welfare of the US public - most notably veterinary scientist contributions to animal models of human health and disease and most critically, in zoonotic diseases. The proposed training program addresses both these essential needs by increasing the pool of veterinarians with exposure to careers in research, and based on the history of the program, it is anticipated that a significant number of these trainees will pursue advanced training in research.